The Role of the EphA2 Receptor Kinase Pathway in Pneumocystis Pneumonia (PCP)

Summary/Abstract
The overall goal of this proposal is to better understand the role of the tyrosine kinase receptor EphA2 signaling
pathway in alveolar macrophages during Pneumocystis pneumonia (PCP). Pneumocystis jirovecii pneumonia
(PJP) remains a significant cause of morbidity and mortality in AIDS1,2. During AIDS and other
immunosuppressive states, the absence of CD4 lymphocytic immunity results in exuberant and often fatal PJP3,4.
Myeloid cells, particularly alveolar macrophages (AMs) are crucial for anti-PJP innate immunity5-8. The binding
of Pneumocystis to alveolar macrophages mediates early host immune response to the fungus9,10. AMs further
promote killing and clearance of organisms but are also major sources of proinflammatory mediators contributing
to profound pulmonary inflammation and lung injury during PJP11-13.
To date, extremely little is known regarding the role of EphA2 receptor and Pneumocystis engagement
in mediating subsequent effects on the host immune response and fungal killing during Pneumocystis pneumonia
(PCP). We have previously shown the importance of the β-glucan receptor EphA2 in Pneumocystis organism
attachment to lung epithelial cells14. Furthermore, we demonstrated that following EphA2 receptor-ligand
engagement with Pneumocystis β-glucan carbohydrates, the tyrosine kinase receptor is activated in epithelial
cells14. Now, our preliminary studies further indicate the importance of the EphA2 receptors on AMs in
inflammatory responses to Pneumocystis. To date, there are no published descriptions of the potential roles of
EphA2 on AMs during fungal infection pathogenesis. We now provide exciting new initial in vivo data
demonstrating that EphA2-deficient mice have significantly less proinflammatory responses and significantly
greater organism burden in both immunocompromised and immunocompetent mouse models of PCP.
We therefore hypothesize that EphA2 receptors signal following Pneumocystis binding to alveolar
macrophages mediating early host immune recognition and response to the organism. In addition, based on our
preliminary in vivo PCP model data, we further hypothesize that EphA2-receptor signaling in AMs is critical for
mounting proper lung inflammation and organism control during PCP. Two Specific Aims are proposed.
Aim 1: We will characterize the function of EphA2 signaling pathways in AMs following in vitro organism
attachment. We will specifically study the resulting cytokine response in AMs, as well as subsequent
organism killing by AMs. To address this, we will examine the function of EphA2 in AMs derived from EphA2
(EphA2-/-) receptor knockout and wildtype mice challenged with mouse derived Pneumocystis murina.
Specifically, we will study the binding kinetics and inflammatory responses following P. murina interactions with
AMs. Initial data from our lab suggests significantly less inflammatory cytokine responses in macrophages from
EphA2-/- versus wildtype controls. Furthermore, we will analyze the uptake and killing of P. murina by
macrophages, as well as cytokine release by these cells challenged with either P. murina as well as isolated
Pneumocystis organism cell wall components.
Aim 2: We will further determine the role of EphA2-signaling on modulating lung inflammation, AM
subset recruitment, and organism burdens in the PCP immunocompetent and immunosuppressed
models in mice. Our preliminary studies demonstrate that CD4-depleted EphA2-/- mice with PCP exhibit
significantly increased organism burdens compared to their wildtype counterparts. Accordingly, we will evaluate
the time course and magnitudes of organism clearance and inflammatory cytokines in wildtype and EphA2-/-
mice. We will directly contrast these parameters in immune competent compared to CD4-depleted mice.
Furthermore, we will directly isolate and assess macrophages derived from both groups of infected mice to
assess their ability to kill Pneumocystis and generate adequate cytokine responses. We will also employ flow
cytometry to further isolate and characterize distinct pulmonary macrophages subset recruitment. This will
include whether the AMs are relatively Type 1 or Type 2 polarized and will further assess the recruitment
of other macrophage populations include tissue-resident alveolar macrophages (TR-AMs), monocyte-
derived alveolar macrophages (Mo-AMs), and interstitial macrophages (IMs). These determinations will be
performed in both mouse strains tested in the PCP models proposed. These studies promise valuable
insights into the role of EphA2 receptor signaling pathway in macrophages during PCP and should provide initial
data that may inform future targeted therapies of this pathway for the treatment of PCP.
We anticipate that these studies will define the importance of the of EphA2 receptor signaling pathway in
organism killing and regulating the host response in PCP. Modulating these pathways may serve as a novel
strategy for therapeutic intervention potentially beneficial to patients with PJP when provided in addition to
traditional antibiotic agents.

Public health relevance
Narrative This proposal evaluates the importance of alveolar macrophage EphA2 β-glucan receptor signaling in host responses to Pneumocystis. Furthermore, we will determine the importance of EphA2 activity in vivo during Pneumocystis pneumonia (PCP) in the CD4 depleted mouse model through analysis of lung inflammation, organism killing, and eventual outcome. Observations from these studies will aid in understanding PCP, and guide development of novel therapeutic approaches targeting this pathway for PCP, for patients who are refractory or fail standard antibiotic therapy.